Investigating the role of chromatin-associated RNA processing in Early B-cell development

Project Summary
B-cells are unique among mammalian cells because of their ability to undergo programmed genomic
rearrangements. The first of these rearrangements is called VDJ recombination and is primarily responsible for
generating the vast diversity of antibodies seen in nature. This is critical for the development of the adaptive
immune system, but generating double-stranded DNA breaks is an enormous risk to the cell, therefore VDJ
recombination must be tightly regulated. My lab has previously shown that VDJ recombination depends on the
RNA exosome’s 3’ RNA processing activity. After losing the RNA exosome Pro-B-cells accumulate non-coding
RNAs throughout the IgH locus. My project seeks to build upon these findings by finding the exact mechanism
through which the RNA exosome and RNA helicases act during VDJ recombination. I will use novel mouse
models to investigate RNA helicases that have been shown to act on chromatin-associated RNAs that I
hypothesize play a role in VDJ recombination. I will confirm these results in a RAG-inducible in-vitro system to
confirm that off-target genomic instability is not causing the defect in VDJ recombination and investigate the
transcriptional status of RNA processing deficient Pro-B-cells. After these experiments, I will perform
experiments to identify the status of the chromatin-associated RNA at the Ig loci and how they affect the
frequency and structure of double-strand breaks at recombination signal sequences. Finally, I will attempt to
rescue the defect by targeting a dCas9-RNAseH construct to sites with increased chromatin-associated RNAs
in helicase or exosome-deficient backgrounds, showing that the helicases and the exosome play an active and
direct role in VDJ recombination, independent of their role elsewhere in the genome.

Public health relevance
PROJECT NARRATIVE The mechanisms underlying VDJ recombination remain poorly understood, especially concerning non-coding RNA processing. In this project, I will use novel tools to test the hypothesis that chromatin-associated non- coding RNAs play a direct role in VDJ recombination. Understanding this link will shed light on the steps involved in lymphocyte development and how B-cells balance genomic instability with antibody diversity.